Novel mitochondria-targeting peptides (MTPs) as therapeutic intervention in Barth syndrome

Mitochondria-targeting peptides (MTPs) as therapeutic intervention in Barth syndrome
Barth syndrome (BTHS) is a serious X-linked recessive multisystem disorder caused by
mutations in the TAZ gene (TAZ, G 4.5, OMIM 300394) that encodes for the
acyltransferase tafazzin. Although BTHS is a multisystem disorder, cardiomyopathy
which may be accompanied by endocardial fibroelastosis (EFE) and/or left ventricular
noncompaction (LVNC) is the most significant clinical manifestation of the disease.
Despite the recently acquired knowledge about its impact on mitochondrial function, there
remains a gap in our understanding of the molecular/metabolic processes that lead to
Barth syndrome associated cardiomyopathy and as a result, there are no FDA approved
therapies specific for Barth syndrome cardiac manifestations. In the absence of such
therapies, improvement in the life expectancy and positive disease outcomes in Barth
syndrome will likely remain elusive. Our proposal addresses the critical need to develop
new effective treatment that address cardiolipin abnormalities, the fundamental defect
underlying BTHS.
Our proposal also has an educational (AREA) component significance. It is expected to
stimulate research at Cleveland State University - an urban institution that provides
baccalaureate and advanced degrees for underrepresented and multicultural students
populations.

Public health relevance
PROJECT NARRATIVE Barth syndrome (BTHS) is a serious X-linked recessive multisystem disorder caused by mutations in the TAZ gene (TAZ, G 4.5, OMIM 300394). Our proposal addresses the critical need to develop new effective treatment that addresses cardiolipin abnormalities, the fundamental defect underlying BTHS. The lessons learned by completion of the proposed studies are expected to have a broader impact for other, more prevalent forms of mitochondrial cardiomyopathies and heart diseases with abnormal cardiolipin content. Our proposal also has an educational (AREA) component significance. It is expected to stimulate research at Cleveland State University providing intensive research experiences to undergraduate and graduate students, giving them the same opportunities available to students at more elite institutions.